Low Profile Transcatheter Aortic Valve Implant

ABSTRACT
Transcatheter aortic valve replacement (TAVR) is gradually becoming an essential alternative to surgical aortic
valve replacement (SAVR) for patients with severe aortic stenosis (AS) at high or prohibitive surgical risk. The
published PARTNER 3 and EVOLUT LOW-RISK trials have recently demonstrated that TAVR can be considered
in low-risk patients. However, the long-term durability of transcatheter prosthetic valves has become a major
concern nowadays, especially for young patients with greater life expectancy. Although increased efficacy and
safety of the current leading TAVR valves (e.g., Medtronic CoreValve and Edwards Sapien) have been reported
lately, tissue valve dysfunction and failure remain the limiting factors for the long-term outcome of TAVR.
Furthermore, the application of those TAVR valves is limited to certain patients due to the use of the relatively
large delivery system (typically 14-16 Fr. Size). There is a substantial clinical desire for a lower-profile delivery
system since it accommodates a greater population of patients with peripheral artery disease or small arteries
and reduces the risk of vascular complications following transfemoral TAVR. It is well known that calcification
plays a major role in the failure of bioprostheses and other tissue heart valve substitutes. Mechanical stress
imposed on the leaflets contributes to the growth of calcium crystals and collagen fibers’ disruption, which
induces thrombosis, calcification, and early valve failure. Therefore, a superior biomaterial with appropriate
mechanical (low stress) and structural (thickness) properties may provide a solution for prolongation of
transcatheter valve durability and size reduction of delivery system. Our group has previously verified that swine
and bovine pulmonary visceral pleura (PVP) are highly elastic and much thinner (~1/3 of the thickness) than
bovine pericardial tissue typically used for the current TAVR valves. The larger compliance and smaller thickness
of PVP make it possible to become a more durable valve leaflet and to be delivered with a lower profile delivery
system (<14 Fr.). Thus, we propose PVP as a potential disruptive biomaterial for constructing bioprosthetic heart
valves. The objective of the SBIR Phase I proposal is to determine the feasibility of the bovine PVP to serve as
the leaflets of TAVR in chronic animals. To accomplish this goal, we set the following two Specific Aims: 1) To
create a transcatheter aortic valve (TAV) from PVP into a smaller delivery profile (12 Fr.), and 2) To assess
chronic in vivo performance of PVP TAVR in juvenile sheep for up to 24 weeks. We have calculated and
tested that bovine PVP leaflets with thickness ≤ 0.1 mm can be crimped in a 12 Fr. catheter without causing
tissue damage. The juvenile sheep model is the gold standard animal model for prosthetic valve testing.
Completion of this study may provide a new type of bioprosthetic material for transcatheter heart valves that
have potential to enhance the valve durability and improve TAVR outcomes. The success of this program would
also deliver significant benefits to patients ranging from adolescents to the elderly with the limited size of the
access arteries.

Public health relevance
NARRATIVE Enhancement of valve durability to meet the increasing life expectancy and size reduction of the delivery system of transcatheter valves are now the major focus of the design of TAVR for the treatment of aortic stenosis. The goal of this study is to develop and validate bovine PVP served as a new type of leaflet tissue of TAVR in a chronic sheep model.